Examining Immune Circuits Responsible for Anamnestic RBC Alloimmunization

Summary: Prior alloimmunization places patients at risk for anamnestic alloantibody formation following
alloantigen re-exposure that can result in accelerated RBC clearance and lead to a potentially fatal delayed
hemolytic transfusion reaction (DHTR). The inability to prevent DHTRs largely stems from a fundamental lack
of understanding regarding key immune pathways that govern anamnestic RBC alloantibody responses capable
of driving DHTRs. Our long-term goal is to identify and then target critical pathways that regulate the development
of anamnestic alloantibody formation. Our central hypothesis is that anamnestic RBC alloantibody formation
occurs through a distinct toll-like receptor (TLR), bridging channel dendritic cell (DC) and follicular (FO) B cell-
dependent pathway that fundamentally differs from primary RBC alloimmunization. Our hypothesis is formulated
on the basis of our discovery that unlike initial RBC alloimmunization, which requires marginal zone (MZ) B cells,
MZ B cells are not required for anamnestic alloantibody formation, but are required for early priming events that
occur following initial RBC alloantigen exposure. In addition to differences in MZ B cell requirements, while initial
alloantibody formation is CD4 T cell independent (TI), increased alloantibody levels observed following RBC re-
exposure is entirely CD4 T cell dependent (TD). Furthermore, while T follicular helper cell (TFH) and follicular
(FO) B cells are not required for initial alloantibody formation, initial RBC transfusion does increase TFH and FO
B cell numbers. Re-transfusion also increases 33D1+ DC activation and chemokine receptor expression. These
results suggest that initial RBC transfusion primes recipients by generating distinct alloantigen-specific TFH and
FO B cell populations that can, in turn, be activated by 33D1+ DCs following RBC alloantigen re-exposure
independent of MZ B cells. In addition, while type I interferons (IFNab) are required for primary alloantibody
formation, TLR signaling is dispensable for initial alloantibody development, yet is required for anamnestic
alloantibody formation. Given the ability of MZ B cells to directly activate CD4 T cells and traffic antigen to the
B cell follicle, our data suggest that initial priming events require MZ B cell-mediated CD4 T cell and FO B cell
development through an IFNab-dependent process. However, as anamnestic alloantibody formation occurs
through a MZ B cell-independent pathway and DCs can also traffic antigen to B cells and directly activate CD4
T cells, DCs likely orchestrate anamnestic alloantibody formation through a TLR-dependent pathway. To test
this hypothesis, we will pursue the following specific aims: Specific Aim 1: Define the role of MZ B cells and
IFNab in the development of CD4 T cells and FO B cells required for a subsequent anamnestic
alloantibody response. Specific Aim 2: Define the role of TLRs and DCs in the development of an
anamnestic alloantibody response following RBC alloantigen re-exposure. Successful completion of these
aims will define key factors that regulate anamnestic alloantibody responses and in so doing provide an important
framework to prevent alloimmunization that leads to DHTRs.

Public health relevance
Narrative: Prior alloimmunization places patients at risk of developing potentially fatal delayed hemolytic transfusion reactions (DTHRs) following red blood cell (RBC) alloantigen re-exposure. Despite the severity of these transfusion reactions, very little is known about the immune factors that govern anamnestic RBC alloantibody formation. This study will leverage clinical and pre-clinical approaches to define the immune factors responsible for the development of anamnestic antibody formation with the long-term goal of identifying key targets that may prevent or reduce alloantibody formation that led to DHTRs.